Characterization of LINE-1 reverse transcriptase activity

Project Summary
The objective of this research proposal is to characterize the enzymatic activities of the reverse transcriptase
(RT) of the human long interspersed element 1 (LINE-1, L1 RT). LINE-1 sequences constitute 17% of the
human genome, and L1 RT activity is responsible for approximately 40% of our genome because it has also
led to the proliferation of short interspersed elements (e.g., Alu), and other retroelements. L1 RT activity is also
implicated as a driving force behind a variety of human diseases such as macular degeneration, Aicardi-
Goutières syndrome, and systemic lupus erythematosus. LINE-1 expression and retrotransposition are
commonplace in numerous cancers, including 90-100% of breast, colon, and esophageal cancers, making
understanding the basic biochemical activity of L1 RT relevant to public health research.
Reverse transcription is key to the ability of LINE-1 to self-propagate in our genome, through a process
known as target-primed reverse transcription (TPRT). L1 RT is encoded by the second open reading frame
(ORF2) of L1, residing in the protein known as ORF2p. In this proposal, I show that I have isolated the ORF2p
RT domain, and that this has RT activity in vitro. I intend to use this protein domain, as well as full-length
ORF2p, and L1 RNPs to fully characterize the biochemical and enzymatic properties of L1 RT. In my first
Specific Aim, I will characterize its processivity, which is an indication of whether the RT stops and pauses, or
whether it keeps going until it reaches the end of a template. I will also measure the fidelity of L1 RT, which
defines how faithfully it copies DNA from an RNA template. Finally, I present preliminary sequencing data
showing that L1 RT has the unexpected ability to begin processing an RNA template without a primer and
propose rigorous experiments to study this feature. In my second Specific Aim, I focus on what happens when
L1 RT reaches the end of its template, which may be crucial to understanding how cells repair intermediates of
transposition. I present preliminary data showing that L1 RT adds extra nucleotides to the end of its cDNA and
propose studies to fully characterize this activity. Additionally, I will study the ability of L1 RT to switch to a
different template at the end of one template and whether LINE-1 RT can use modified RNA as a template,
such as the pseudouridine found in mRNA vaccines or the naturally occurring N6-methyladenosine
modification.
This work will advance our understanding of how LINE-1 operates inside cells and how LINE-1
completes its life cycle. The proposed research will have implications for cancer biology and innate immune
signaling where L1 RT is increasingly recognized as a DNA damaging agent and trigger for pattern recognition
receptors, respectively. Finally, this research will give insight into the evolution of LINE-1-like retroelements
that are found across all kingdoms of life.

Public health relevance
Project Narrative Nearly 40% of the human genome has been copied from RNA by means of the LINE-1 reverse transcriptase (L1 RT), and L1 RT activity has been proposed as a contributor to a wide variety of human diseases and malignancies. This application proposes to investigate the biochemical properties of L1 RT with the goals of understanding its enzymatic activities and creating a fundamental knowledge base for understanding its roles in disease.